Yale-SCORE Career Enhancement Core

Sex interacts with alcohol in a complex manner and differences exist in pharmacokinetics and
pharmacodynamics, health-risks and consequences, risk factors of initiation and maintenance, immune
response, neurodegeneration, withdrawal neurotoxicity, stress-reactivity, psychiatric co-morbidities, and sociocultural
factors. The Career Enhancement Core of the Yale-SCORE will address the dramatic need for
interdisciplinary and translational scientists focused on applying a sex focus to the study of alcohol use. Our
primary aim is to provide qualified PhD and MD junior faculty with translational team mentorship and salary
support to enhance their research career development focused on sex differences and alcohol science. Each
year we will support SCORE-Early Investigators (meeting the definition of NIH Early-Stage Investigator) for 2
years, with 50% of their time protected to engage in career enhancement activities. SCORE-Early Investigators
will be recruited nationally, with well-developed plans to recruit excellent candidates. Career enhancement
activities include: 1) mentored research, leading to K or R award submissions; 2) access to pilot funds
supporting research focused on sex differences and alcohol; and 3) a curriculum dedicated to education
regarding sex differences and alcohol science. Finally, we will provide SCORE-Early Investigators with
professional development and leadership skills necessary for an academic career. Strengths of this Core
include: a) an intensive focus on team mentoring and career enhancement; b) creation of a cohort of early
career peers who can provide support and share experiences; c) mentors, who are established investigators
with broad expertise in translational, alcohol, and SABV science; d) strong integration and synergy with the
Yale-SCORE and with other training programs at Yale; and e) a successful track record of previous trainees.

Public health relevance
CAREER ENHANCMENT CORE NARRATIVE The Career Enhancement Core of the Yale-SCORE contributes to public health by responding to the dramatic need for interdisciplinary and translational scientists, focused on applying sex differences science to the study of alcohol use. The Career Enhancement program provides: a team of mentors who are leaders in interdisciplinary, translational, alcohol, and sex differences science; salary support for junior faculty; a pilot project program; and a core curriculum that provides foundational knowledge, professional development and leadership training.